Nitric Oxide-Soluble Guanylate Cyclase Pathway as a Target for Male Bladder Outlet Obstruction and Lower Urinary Tract Symptoms in Aging

Abstract
Benign Prostatic Hyperplasia (BPH) is a highly prevalent health issue exhibited by ~50% of men by age 50, and
75% by age 80 which may be associated with bladder outlet obstruction (BOO) and lower urinary tract symptoms
(LUTS). First line treatments include α1-adrenoceptors antagonists (e.g., tamsulosin) to decrease smooth muscle
tone in the prostate and bladder neck and 5α-reductase inhibitors (e.g., finasteride) to block conversion of
testosterone to more potent dihydrotestosterone for reducing prostate volume. However, these agents are often
ineffective in preventing disease progression to urinary retention which may necessitate surgical intervention in
many patients. Multiple lines of evidence support that apart from aging, the pathogenesis of LUTS comprises
multiple modifiable factors including compromised prostatic perfusion, oxidative stress mediated inflammation,
fibrosis, and neuroplasticity. Clinical evidence argues against “one size fits all” therapy and highlights the
preference of treatment options with lower risk of sexual side effects which is underscored by the FDA approval
of phosphodiesterase-5 inhibitor (PDE5I), tadalafil, and its recent (2021) combination with finasteride (i.e.,
Entadfi) as a single pill for BPH/LUTS. Since some patients develop refractoriness to tadalafil, there is a
compelling reason to advance our understanding of nitric oxide (NO•)-cGMP signaling in the pathophysiology of
BPH/LUTS. The canonical target for NO• is soluble guanylate cyclase (sGC) that catalyzes the production of
cGMP. The responsiveness of sGC is dependent upon cytochrome B5 reductase-3 (CYB5R3) that maintains
the sGC heme in the NO• sensitive reduced state (Fe2+). We recently reported that aged (≥24 mo) male mice
without hormonal manipulation recapitulate the BOO phenotype of high bladder pressure/low urine flow
compared to low pressure/high flow of adult mice (9 mo), and that daily oral treatment with the sGC activator,
cinaciguat (10 mg/kg/2 wks) reversed prostate hyperplasia and BOO in these aged mice. We propose that the
aged mouse is a suitable model for testing our novel hypothesis that BPH/LUTS arises in the milieu of age-
related oxidative stress potentiating the neurodegeneration of NO• producing (nitrergic) nerves and
inflammation-induced inactivation of CYB5R3 to decrease cGMP-PKG signaling. The vicious feed forward cycle
of BPH/LUTS can be circumvented by cinaciguat, a heme mimetic that can stimulate cGMP production when
sGC is oxidized and the heme displaced, while its combination with a PDE5I can check PDE5 upregulation due
to prolonged elevation of cGMP. This is supported by our selective knockout (KO) of CYB5R3 in the
prostate/bladder, with both models to be compared with prostatic tissue from aged men with BPH. Our aims are:
1) Probe the role of the NO•-sGC-cGMP signaling pathway in the pathogenesis of BPH/BOO/LUTS in aged mice
with cinaciguat treatment; 2) Study the impact of tissue specific deletion of CYB5R3 in the prostate or bladder in
our conditional KO mouse; and 3) Determine if cinaciguat/PDE5I combination therapy can override PDE5
overexpression driven refractoriness to PDE5Is and any untoward cardiovascular effects that may occur with
cinaciguat.

Public health relevance
Narrative Benign Prostatic Hyperplasia (BPH) is a highly prevalent global health issue exhibited by ~50% of men by age 50, and 75% by age 80, which may be associated with bladder outlet obstruction (BOO) and lower urinary tract symptoms (LUTS). Standard treatments are often ineffective in preventing disease progression and consequent urinary retention necessitating surgery. We hypothesize that aging disrupts the nitric oxide (NO•)-soluble guanylate cyclase pathway to promote the pathogenesis of BPH/BOO/LUTS, therefore the aims of this proposal are to elucidate this pathway in aged male mice and adult mice with selective CYB5R3 knockout in the prostate or bladder, and the mechanism of action underlying the therapeutic effect of soluble guanylate cyclase activator, cinaciguat.